Pediatric Biopsychology Core

Project Summary/Abstract
This COBRE aims to build a program for supporting excellence and innovation in research addressing sleep, circadian rhythms (CR), and mental health. Resources that bridge sleep and CR science and pediatric mental health research are limited, and opportunities for research training in these areas lack a coordinated system to link these important and interconnected constructs. The overall objective of the Pediatric Biopsychological Core (PBC) is to address this gap by connecting promising researchers to experienced mentors and creating a supportive infrastructure for enhancing research that includes evidence-based assessment of mental health, sleep, and the collection of biospecimens. To support this overarching goal, the PBC aims to 1) develop a culture of excellence by coordinating the administration of evidence-based assessment measures and practices; 2) provide resources for data collection, management, and analysis and the use of technology- based resources in the study of biopsychological factors in the context of sleep and circadian rhythms; and 3) provide resources for collection, storage, and processing of biospecimens. The PBC will offer Project Leaders individualized guidance for assessments of pediatric biopsychology. The PBC will also support Project Leaders in using rigorous data management procedures in accordance with current best practice and open science guidelines. The Core will also maintain a secure, HIPAA-compliant database to store multimodal and intensive data streams that will include shared assessment batteries as a resource for current and future research. The long-term goals of the Core are to 1) develop a sustainable resource for pediatric psychological assessment and biospecimens to enhance and promote high-quality research at Bradley Hospital; 2) provide resources for the management and analysis of these data; and 3) consistent with NIH priorities, develop a combined, centralized database with an eye towards data harmonization. Achievement of these aims will result in enhanced research infrastructure by providing a measurement resource that can help researchers integrate the demands of clinical care with the common domains articulated in the NIMH Research Domain Criteria (RDoC) framework. Having a center of excellence focused on measurement will greatly facilitate the research of COBRE-affiliated projects as well as research across the hospital and other Rhode Island facilities by helping to harmonize the assessment of common domains across clinical care and research projects. This COBRE will ensure that Bradley Hospital continues to be a state-wide and national leader in both research and care of children and adolescents with sleep and mental health concerns.